TARGETING MASH WITH NOVEL SMALL MOLECULE TXNIP INHIBITOR

Metabolic dysfunction-associated steatotic liver disease (MASLD) and steatohepatitis (MASH) (aka NAFLD and
NASH) affects 1 billion people, yet no approved therapy is available. Interestingly, our new antidiabetic small
molecule thioredoxin-interacting protein (Txnip) inhibitor, TIX100, effectively protected obese and diabetic mice
against steatosis and showed anti-inflammatory, anti-fibrotic effects in a non-diabetic, non-obese, model of
MASH. Of note, Txnip is known to promote oxidative stress, apoptosis and inflammasome activation and to be
elevated in livers of humans and mice with NAFLD/NASH. Thus, our overall hypothesis is that TIX100
protects against MASLD/MASH by improving glucose and lipid homeostasis and inhibiting inflammation
and fibrosis. We propose 3 Specific Aims: #1: Determine the therapeutic effects of TIX100 in the context of
diet-induced obesity and non-obese MASLD and MASH models. #2: Define the cellular TIX100 effects controlling
MASH-associated inflammation and fibrosis and #3: Elucidate the molecular mechanisms underlying the
beneficial effects of TIX100 in MASLD/MASH. To this end, we will assess liver histology, markers for lipogenesis,
inflammation and fibrosis, hepatic and circulating lipids, and liver dysfunction, as well as any potential changes
in whole body metabolism. This will be done in the context of MASLD, induced by high-fat diet obesity and of
MASH and fibrosis, induced by a validated choline-deficient L-amino acid-defined high-fat diet. Involvement of
carbohydrate response-element-binding protein, a key transcription factor of Txnip and lipogenic genes will also
be determined by liver chromatin-immunoprecipitation studies. In addition, we will elucidate the specific TIX100
effects on hepatic stellate cells (HSC) and fibrogenesis, Kupffer cells and inflammation and cell autonomous
effects using isolated primary hepatocytes. Using liver microRNA sequencing, we further discovered miR-34a
as the top microRNA downregulated by TIX100. Intriguingly, miR-34a has been reported to promote lipogenesis
and inflammation and to be upregulated in livers of humans and mice with MASLD/MASH. Now, our preliminary
studies reveal that TIX100 treatment reduces the elevated miR-34a levels of MASLD/MASH and we will therefore
continue to define the effects of TIX100 on miR-34a signaling in our liver, hepatocyte and HSC samples. To
validate Txnip as a TIX100 target in the treatment of MASLD/MASH, we will take advantage of our whole body
and liver cell-specific Txnip-deficient mouse models and expose them to DIO and CDAA-induced MASLD/MASH
with and without TIX100 treatment. This will allow us to tease apart any Txnip-mediated (and potential Txnip-
independent) effects and further define the mechanism(s) of TIX100 action in the treatment of MASLD/MASH.
Thus, the results of these studies will provide mechanistic insight and critical preclinical data for the
development of novel therapeutic approaches for MASLD/MASH at the intersection of metabolism, inflammation,
and fibrosis. Since TIX100 has already undergone extensive preclinical safety toxicology and pharmacokinetic
studies in preparation for first-in-man trials, the proposed studies also promise a high translational impact.

Public health relevance
Project Narrative Metabolic dysfunction-associated steatotic liver disease (MASLD) and steatohepatitis (MASH) (previously known as NAFLD and NASH) are the most common liver diseases and often associated with diabetes and obesity. However, mechanisms underlying these diseases and thus, treatments directly targeting the mechanistic drivers are lacking. As such, this application proposes to study a promising novel small molecule antidiabetic drug candidate and its distinct underlying cellular and molecular mechanisms as a potential novel approach and future therapeutic against these metabolic liver diseases.